International Society for Environmental Epidemiology (ISEE) Annual Conference

ABSTRACT
The International Society for Environmental Epidemiology (ISEE) is the premier scientific society in
environmental epidemiology. Its primary objective is to promote the expansion and dissemination of scientific
knowledge focusing on relationships between environmental exposures and their associated health
consequences in human populations. The ISEE provides a variety of forums for exchange of information; one
of the most important of these is their annual conference. This conference represents the most prominent and
comprehensive gathering of environmental epidemiologists and related environmental health professionals
from academia, government, and other organizations from around the world. It provides a forum for discussion,
critical review, collaboration, and education concerning problems unique to the study of public health and the
environment, all with the ultimate goal of ameliorating the public health impacts of environmental agents.
In the next three years of this conference, we are excited to capitalize on, and help address, the attention
focused on the environment and health at this time throughout the world. These will include: 1) the 32nd Annual
meeting in Washington, DC, USA, (August 23-27, 2020) with the overall theme being "Advancing
Environmental Health in a Changing World" (https://isee2020dc.org/); 2) Beijing, China – September, 2021,
with the Theme: “Environmental Health Challenges in Low and Middle-Income Countries”; and, 3) Athens,
Greece – September, 2022, with the theme: “Strengthening the global role of environmental epidemiology.”
The annual meeting offers three and a half days of cross-disciplinary examinations of new research and
methods of international, national, and regional significance. The conference facilitates the exchange of
information and ideas among epidemiologic investigators and public health practitioners, and it is one of the
most important global forums for the presentation of human health research as it relates to the contamination
of vital natural resources such as air and water, living environments, and systems supporting food production.
Importantly, the meeting is also an important venue for education, training, and promotion of junior
investigators and investigators from developing countries. Scholarships will be provided to distinguished
experts, young investigators, students, and promising scientists from the US and developing countries in order
to enhance and diversify the global development of environmental health work forces, and foster collaborations
and information exchange both nationally and internationally.

Public health relevance
The ISEE annual conference plays a vital role in facilitating dialogue among leading environmental epidemiologists. The conference represents the most prominent and comprehensive gathering of environmental epidemiologists and related environmental health professionals from academia, government, and other organizations from around the world. It provides a forum for discussion, critical review, collaboration, and education concerning problems unique to the study of public health and the environment all with the ultimate goal of ameliorating the public health impacts of environmental agents.